EVALUATION OF PATIENTS WITH UNRESOLVED CHROMOSOMAL ABERRATIONS

This project will use spectral karyotyping and whole genome microsatellite analysis to characterize chromosomal aberrations that cannot be characterized by light microscopic techniques. We will accrue patients with derivative chromosomes and abnormal phenotypic features and perform SKY analysis and microsatellite analysis. The project is on hold awaiting accrual of appropriate subjects.